Novel Therapeutics for Treating Opioid Use Disorder

PROJECT SUMMARY
Opioid Use Disorder (OUD) is a prevalent issue in the United States, characterized by the chronic misuse
of opioids, resulting in severe consequences such as fatal overdoses, infectious diseases, increased crime rates,
and socioeconomic burdens. Despite the availability of treatment options, OUD remains a significant global
challenge. The current FDA-approved therapies for OUD include methadone, buprenorphine, and naltrexone.
However, these treatments have limitations, including failure to treat all OUD patients, frequent clinic visits, and
low retention rates. To address these challenges, this project aims to develop and explore alternative
approaches fordrug delivery that can optimize therapeutic outcomes for individuals with OUD. Specifically,
this proposal investigates the therapeutic potential of Nor-Levo-α-acetylmethadol (nor-LAAM). Nor-LAAM is an
active metabolite of Levo-α-acetylmethadol (LAAM), an FDA-approved drug to treat OUD. LAAM is a high-
efficacy agonist at Mu Opioid Receptors (MOR) and was administered orally three times a week, showing
promising results in reducing opioid-positive urine tests, incarceration rates, and prolonged abstinence. However,
it was reported that LAAM is associated with cardiovascular risks, specifically QT prolongation and torsades de
pointes (TdP). Previous studies have shown that QT prolongation is primarily attributed to the parent drug LAAM
itself rather than its metabolite nor-LAAM, as nor-LAAM exhibits a higher IC50 of 12 μM to inhibit HERG potassium
channels compared to 3 μM of LAAM. Additionally, nor-LAAM is more potent at MOR than LAAM. This proposal
involves utilizing biodegradable polymers to develop nor-LAAM-loaded polymeric microparticles (Nor-LAAM-MP)
with in vitro sustained release capabilities (≥1 month) suitable for subcutaneous administration to treat OUD. We
hypothesize that these microparticles will enable a controlled release of nor-LAAM, thereby reducing dosing
frequency and drug dose and enhancing patient adherence while mitigating the risk of drug-related adverse effects
and potential toxicities. We plan to conduct pharmacokinetics, efficacy, and safety studies. By completing this
project, we can enhance our understanding of the therapeutic potential and safety profiles associated
with nor-LAAM-MP for treating opioid use disorder.

Public health relevance
PROJECT NARRATIVE As per the National Institute on Drug Abuse (NIDA), opioid use disorder (OUD) remains the primary cause of opioid overdose deaths; however, current treatments have limitations, including reduced efficacy and undesired side effects, highlighting the need to develop more effective and safer therapies. Studies have shown that LAAM (Levo- α-acetylmethadol), a MOR agonist, is more effective in mitigating OUD-related risks than methadone, and its metabolite nor-LAAM has shown to be more potent and safer at MOR 4,5. We propose developing a sustained- release (≥1 month) microparticle formulation of nor-LAAM that would be administered subcutaneously to bring a safe and effective therapy to the limited number of existing treatments for individuals battling OUD.